Sleep Disturbances During Cocaine Abstinence, Dopamine Adaptations, and Motivation for Cocaine

Project Summary/Abstract
Cocaine use disorder is a chronic disease and currently no approved pharmacotherapies exist for its treatment.
Among the greatest challenges in the treatment of cocaine use disorder is prevention of relapse to drug use. In
rats, periods of abstinence following cocaine use intensifies seeking and motivation for drug, which has been
associated with increased propensity for relapse. Although extensive evidence indicates that mesolimbic
dopamine influences cocaine reinforcement, the involvement of dopamine in the regulation of sleep has received
comparatively less attention. We recently demonstrated that the dopamine transporter governs diurnal
fluctuations in extracellular dopamine tone in the nucleus accumbens and that dopamine uptake fluctuates
across the sleep/wake cycle, which impacts the effects of cocaine at inhibiting the dopamine transporter.
Moreover, our preliminary and recently published data suggest that sleep disturbances that occur during
abstinence promote cocaine seeking and that alterations in dopamine transporter function in the nucleus
accumbens may contribute to these effects. Together, these findings raise the possibility that dopamine
neurotransmission in the nucleus accumbens may function as a node that integrates both motivational and
sleep/wake processes. In the proposed studies, we hypothesize that cocaine-related sleep disruptions during
abstinence contribute to dopamine transporter adaptations that promote incubation of cocaine seeking and
increase dopamine transporter sensitivity to cocaine. Further, we propose that restoration of rapid-eye movement
sleep and/or normalization of dopamine transporter function during abstinence will attenuate incubation of
cocaine seeking and reduce dopamine transporter sensitivity to cocaine. Completion of the proposed
experiments will offer new insights into the link between sleep disruptions and development of cocaine seeking,
and the extent to which this involves alterations in dopamine neurotransmission in the nucleus accumbens.
Consequently, expected results should significantly inform the field and help to identify future treatment
strategies for cocaine use disorder.

Public health relevance
Project Narrative The progressive intensification of drug craving/seeking across periods of drug abstinence poses a significant challenge for avoiding relapse to drug use. In the proposed experiments, we will use sleep electrophysiology, neurochemistry, biochemistry, and viral approaches to examine the extent to which sleep disruptions during cocaine abstinence contribute to dopamine terminal adaptations and persistent seeking and motivation for cocaine. Completion of the proposed experiments will reveal whether normalizing sleep or dopamine transporter expression and function is sufficient to prevent seeking and motivation for cocaine.